PROTOCOL 161-101--INVESTIGATION OF CP-101,606 IN PARKINSON'S DISEASE

This study will examine the effects of CP-101,606 on the symptoms of patients with Parkinsons Disease. The study will also assess the safety and tolerability of CP-101,606. This protocol has now been terminated.